Profiles of Common and Unique aspects of Upper Motor Neuron degeneration in HSP and ALS

ABSTRACT/ PROJECT SUMMARY:
The movement starts in the brain. Especially for motor neuron diseases, which impact voluntary movement, the
brain component requires better understanding and assessment. Upper motor neurons (UMNs), located in layer
5 of the motor cortex, have a unique role for the initiation and modulation of voluntary movement. Their
progressive degeneration is the characteristic hallmark of neuropathology observed in hereditary spastic
paraplegia (HSP) and amyotrophic lateral sclerosis (ALS) patients. In striking contrast to their clinical importance
and relevance, very little is known about the underlying causes of their vulnerability and progressive loss. This
lack of information and understanding of the cellular and genetic basis of their vulnerability, as well as the
common and unique aspects of their neurodegeneration hinders our ability to develop effective and long-term
treatment strategies for diseases of the UMN.
In an effort to bring a mechanistic insight into the cellular and molecular basis of UMN degeneration in two distinct
diseases, such as HSP and ALS, we are going to take advantage of the UCHL1-eGFP mice, a reporter line in
which the UMNs are genetically labeled with fluorescence. In this proposal, we will focus our attention to the
Profilin and Spastin, because like Spastin, Profilin is an actin/tubulin-binding protein, and mutations in profilin
results in ALS, whereas mutations in spastin results in HSP. To date numerous mouse models are generated
to mimic the human condition. We crossed the hPFN1G118V (generated by Dr. Kiaei) and SPASTC448Y mice
(generated by Dr. Baas) with UCHL1-eGFP mice to generate the UMN reporter lines with these mutations. Since
we have shown that the UMNs of ALS patients with TDP-43 pathology and mouse UMNs of TDP-43 model share
the same aspects of neurodegeneration at a cellular level, we will focus our attention to the neurons and purify
diseased UMNs from the complex structure of the brain as a “pure” neuron population at different stages of the
disease to investigate the dynamic changes in their gene expression profile as well as the proteins that are
present in them, with respect to the healthy UMNs. As an internal control, we will use UMNs isolated from TDP-
43 mouse model not only because TDP-43 pathology is widely observed in ALS and HSP, but also because this
model better represents the spectrum of ALS.
Upon completion, our results will begin to reveal the common and unique aspects of UMN vulnerability in HSP
and ALS, it will also suggest the distinct set of genes and/or proteins that are responsible for the initiation of their
vulnerability. Most importantly our results have the potential to identify druggable targets and pathways of interest
for future therapeutic interventions.

Public health relevance
NARRATIVE Even though upper motor neurons degenerate in HSP and ALS patients, we still do not know whether these diseases are distinct or share common mechanisms. Using pure populations of upper motor neurons that are diseased due to HSP and ALS pathologies, we will investigate the dynamic changes in their gene expression profile and metabolomic alterations during pre- symptomatic and symptomatic stages of neurodegeneration. Our results will reveal the common and unique aspects of upper motor neuron vulnerability and progressive degeneration in ALS and HSP, and will lay the foundation for future detailed therapeutic strategies for these upper motor neuron diseases.